Leveraging Sexual Dimorphism to Predict Cardiac Remodeling and Enhance Treatment in Women with Severe Aortic Stenosis

ABSTRACT
Women with severe aortic stenosis (AS), a condition characterized by the narrowing of the aortic valve opening,
often experience delayed diagnosis, undertreatment, and higher mortality rates compared to men, indicating
both delayed care-seeking and a lack of appropriate diagnostics and monitoring for female patients. Yet, the
influence of anatomical and functional differences in the female population on AS presentation, management,
and outcomes remains poorly understood. Furthermore, despite the prevalence of symptoms, women with
severe AS receive less aortic valve replacement (AVR) treatment and have higher excess mortality rates over a
five-year period compared to men.
Our proposed project integrates innovative medical image processing and computational modeling
methods, such as statistical shape analysis (SSA), convolutional neural networks (CNN), and inverse finite
element analysis (FEA), to gain sex-specific insights into cardiac remodeling and dysfunction, with a
specific focus on severe AS in women. By focusing on cardiac remodeling, a consequence of prolonged aortic
valve disease, our goal is to enhance AS treatment for women by considering sex-specific differences in
ventricular responses to AVR-induced afterload. To achieve this, we will develop a personalized, mathematical
approach that leverages sex-differentiating anatomical and functional characteristics of the left ventricle (LV),
ultimately aiming to improve survival outcomes. Additionally, we will compare the predictive value of these sex-
differentiating measures to traditional indices, enhancing our understanding of their effectiveness in guiding
clinical management. We hypothesize that advanced anatomical metrics (e.g., shape scores) and material
characteristics (e.g., cardiac stiffness) are superior predictors of post-intervention cardiac events and dysfunction
compared to traditionally collected clinical measures. Our research consists of two main aims. Aim 1 involves
developing a fully automated, neural network pipeline to segment clinical images, creating an advanced SSA
model to extract hidden geometrical features, and establishing a correlation between shape scores and post-
intervention clinical events. This analysis will assess the predictive power of sex-specific measures compared to
the male population, cases where sex is not considered in the model training, and universal clinical indices. Aim
2 focuses on developing a computational tool to estimate patient-specific stiffness of the inhomogeneous LV
tissue, with an examination of its potential value in predicting diastolic dysfunction and AVR outcomes.
Our research serves as a steppingstone to guide clinicians in preprocedural patient selection, optimize surgical
timing, and improve survival outcomes. By developing a sex-specific risk stratification tool and a mechanistic
framework for effective prognosis, we aim to provide valuable means to enhance treatment and mitigate
devastating events associated with severe AS, particularly for female patients.

Public health relevance
PROJECT NARRATIVE Women with severe aortic stenosis face delayed diagnosis, undertreatment, and higher mortality rates compared to men, highlighting the need for improved diagnostics and treatment strategies for female patients. By integrating innovative medical image processing and computational modeling methods, our project aims to gain sex-differentiating insights into cardiac remodeling and dysfunction in severe aortic stenosis among women, with the goal of enhancing treatment outcomes. By providing valuable insights, our research serves as a basis for guiding clinicians in patient selection, optimizing surgical timing, and ultimately enhancing survival rates for female patients with aortic stenosis in future.